EFFICACY OF PERIACTIN IN PROMOTING WEGHT GAIN IN GROWTH RETARDED CHILDREN

Double blind randomized cross over trial assessing the efficacy of Periactin on dietary intake and anthropometric measures in developmentally retarded children.